Likely responder analysis and tests of model misspecification in randomized controlled trials of treatments for Alcohol Use Disorder

Project Summary/ Abstract
We have developed a strategy for the analysis of randomized clinical trials (RCTs) using a potential outcomes
causal framework. Likely responders (LRs) to a test treatment T are identified at the end of the trial and a
statistical test of the difference between T and placebo, P in this enriched sample is performed. LRs are identified
at the end of the trial by fitting a model, called a prognostic score function, that estimates the expected response
to T as a function of baseline features. The LR subset comprises individuals whose expected response exceeds a
pre-specified clinically defined minimum. Identifying LR achieves an important goal of precision medicine. The
causal effect of T compared to P among LRs is appraised based on the observed outcomes within strata of
samples matched on their prognostic score. It is well known that, especially for subsets of a random sample,
misspecification of the model can lead to spurious conclusions. To protect against this possibility in the
estimation of the prognostic score, we have adapted an approach, novel to RCTs, that we call the RCT dry run
(DRrct) diagnostic. It formally evaluates the potential for model misspecification. The value of the LR method
has been demonstrated in a reanalysis of a large multisite 26-week long double-blind RCT of extended release
gabapentin enacarbil (GE-XR) compared to placebo for the treatment of alcohol use disorder (AUD). Substantial
benefits of treatment with GE-XR were found for the subset of patients predicted to be LRs based on their clinical
features. In this research project, we will explore new statistical and machine learning modeling strategies for
the prognostic score function and expand our knowledge of the statistical properties of the LR and DRrct
methods. The goal is to minimize bias and increase precision in estimation of the prognostic score model and
increasing power to test treatment effects in the LR subpopulation. To accomplish this we will use three
strategies: analytic/theoretical methods where possible, simulation of RCTs and the reanalysis of six NIAAA
RCTs comparing treatments for AUD. Although in most of the six trials, no treatment differences were found, it
may be that LR subgroups can be identified whose members obtain substantial clinical benefit. Each reanalysis
will utilize the DRrct method to appraise the possibility of model misspecification. The LR method has the
potential to change standard practice for the analysis of RCTs, reduce the rate of failure caused by analyses
limited to whole sample mean differences, and facilitate personalized medicine; the DRrct method has the
potential to reduce the rate of irreproducible RCTs; and the reanalysis of the six NIAAA studies has the
possibility of uncovering clinically meaningful relationships between patient characteristics and likely
responders to previously studied candidate AUD treatments.

Public health relevance
Project Narrative The proposed research is highly relevant to public health and specifically to alcohol use disorder, one of the most prevalent mental health disorders, because it will produce a new approach to the analysis of a randomized clinical trial that furthers precision medicine. The new method identifies patient specific predictors of likely response to a test treatment and performs hypothesis tests for treatment differences in the group of likely responders, all in the same study. The method will be applied to data from six completed NIAAA studies and a new method for appraising possibly erroneous model specification and confounding will be utilized.